BLRD Research Career Scientist Award Application

I have been associated with VA since 2005 and have been a VA Merit award funded investigator since 2012. I
study lipid metabolism and signaling in cardiovascular and metabolic disease with a focus on functional
validation of the PLPP3 lipid phosphatase gene which we cloned in the late 1990s as a determinant of
heritable cardiovascular disease risk. Our research has identified a lipid signaling pathway that promotes
vascular inflammation and associated pathologies including atherosclerosis and calcific aortic valve disease,
both of which have a higher incidence in Veterans than the general population. Our findings suggest new
approaches for diagnosis and therapeutic management of these conditions. I have authored 287 peer
reviewed research reports with a total of ~25,000 citations (~70 papers are cited more than 100 times, 6 have
more than 500 citations) and this includes (in most cases as a VA affiliated investigator) publications in highly
selective journals. I have a strong record of professional service, local and national service to VA and of
collaboration with other VA investigators (61 publications with 6 different researchers). My laboratory has been
a productive training environment for pre- and post-doctoral fellows who have been recognized by highly
competitive awards including NIH F and K series grants and some of these individuals are now successful
independent established academic investigators. To support our lipid research, and with VA support for two
Shared Equipment Evaluation Program grants, I developed expertise in biomedical mass spectrometry which
is now a major focus of my program. Through my role as core facility director and my association with the
NIEHS supported Superfund and Environmental Diseases Core Centers at the University of Kentucky I
became actively involved in development and application of analytical methods to study human health effects
of exposure to environmental chemicals. This is the area of my VA research that I highlight in this application.
Exposures to chemicals in the environment are an acknowledged determinant of health risk and a particular
concern for veterans and active-duty military personnel as recently acknowledged by the Honoring our Promise
to Address Comprehensive Toxics Act of 2022 (PACT-Act). Our analytical laboratory at CAVHS supports VA
and DOD funded efforts to understand health effects of exposure to per and polyfluorinated alkyl substances
(PFAS) which are manmade surfactant chemicals with widespread use for military firefighting. Exposure to
high levels of PFAS is associated with increased risks of several cancers, dyslipidemia, endocrine and immune
dysfunction in exposed individuals. Our primary project examines PFAS exposure in military firefighters and
construction workers enrolled in the Million Veteran Program (MVP) and its progenitor the Millennium Cohort.
Building on this work we are developing a facile, inexpensive, minimally invasive approach to monitor Service
Member exposure to different classes of environmental chemicals using finger stick blood collection, dried
blood spots, and large-scale targeted and untargeted analytical methods. This will eventually enable routine
biomonitoring and screening of veterans and service members to support creation of a longitudinal exposure
data repository. This would become a central component of larger scale assessment of environmental
chemical exposures in military populations to inform strategies to mitigate risk in exposed individuals. These
are necessarily team-based efforts where we our role is to provide accurate measurements of circulating
environmental chemicals that are then used by statisticians and epidemiologists using multivariate models to
identify associations between environmental chemical exposures and risk of non-communicable diseases. My
efforts at CAVHS are well aligned with the intent of VA to establish a managed research portfolio in the broad
area of Environmental Exposure (Military Exposure Research Program) and with VA/DOD involvement in the
Cancer Moonshot Initiative notably the Project for Military Exposures and Toxin History Evaluation in US
Service Members (PROMETHEUS). The Career Scientist Award would support my effort on these projects.

Public health relevance
The overarching goal of my program is to understand how genetic and environmental factors interact to determine non communicable disease risk. For the past 15 years my VA supported research has characterized and validated a lipid signaling pathway as a unique determinant of heritable cardiovascular disease risk. To support these studies, we developed expertise in biomedical mass spectrometry which has become a major focus of my work. This latter issue is of great concern to veterans and active-duty military personnel as recently acknowledged by the Honoring our Promise to Address Comprehensive Toxics Act. I have set up an analytical laboratory that can measure multiple classes of environmental chemicals in small volumes of human biofluids. This laboratory is currently supporting population health studies of health effects of per and poly fluorinated substances using the Million Veteran Program and I am more broadly involved in efforts to enable routine biomonitoring of environmental exposures across the lifespan of Veterans and Service Members.